Modeling Correlated Signals in Memory Systems

Project Summary
The dominant method for measuring short- and long-term memory in the laboratory is a
straightforward recognition memory test in which people are presented with a single item and
asked whether the item was or was not seen during the experiment. Recent work in the
eyewitness domain suggests, however, that when people are presented with multiple similar
items at test —instead of a single item at test— their memory performance is facilitated.
However, currently there is no mechanistic explanation regarding how presenting similar items
at test may improve memory. Furthermore, the formal study of this effect of similar items has not
been extended outside of the context of eyewitness memory. It is virtually unexamined in the
context of other memory systems, particularly, long- versus short-term memory, or stimuli that
are similar in different ways (i.e., across visual versus semantic dimensions). The aim of this
proposal is thus two-fold. The overarching aim is theoretical: To develop and test a theoretical
framework for how correlations amongst memory signals at test may arise from shared neural
populations representing items, and may facilitate memory. Not only will the project ask how
generalizable previous work from the eyewitness domain is, but a major novel aspect of the
project approach to this problem is that it will leverage computational modeling to develop an
integrative theoretical framework that helps address the question of how, specifically, similarity
between items presented at test facilitate memory. The second aim is empirical: To examine
how generalizable the finding is that similarity amongst stimuli presented at test affects memory,
across the long- and short-term memory systems, and for stimuli that are related on visual and
semantic dimensions. Thus, the project will be the first to test these effects across the study of
different memory systems, and across the study of items that are related based on their
semantic or visual similarity. Regardless of what empirical results are obtained, this line of work
will have broad implications for memory researchers and practitioners because it will, for the first
time, provide insight into the generality or boundary conditions for the effects of similar items in
memory test; furthermore, the current work will equip cognitive neural researchers with the
conceptual and computational tools to examine the neural signatures of these effects.

Public health relevance
Project Narrative Memory processes underpin the ability to learn from the past and to plan for the future, making them core to rudimentary (e.g., remembering to go to work) and more sophisticated (e.g., giving a lecture) types of behavior. The aim of the proposed work is to leverage computational modeling to develop an integrative theoretical framework that elucidates the question of how to optimally test people’s short- and long-term memory for different memoranda. This work will be essential to behavioral researchers who aim to understand how memory processes vary as a function of experimental manipulations or individual differences, as well as clinical researchers who seek valid and precise measurement tools to evaluate signs of memory dysfunction or disease, such as those that index onset of dementia or schizophrenia.